Adult and Pediatric Nephrology and Urology Research Training Program

PROJECT SUMMARY
This renewal T32 application entitled “Adult and Pediatric Nephrology and Urology Research Training
Program” seeks to extend funding to a thriving research training program in the NIDDK mission areas of adult
and pediatric nephrology and (benign) urology. Key features of the Program include: 1) an energetic, highly
motivated Program Director with a very strong track record of research training, NIH funding, and publication of
high impact manuscripts; 2) an experienced, dedicated Executive Committee with expertise in adult and
pediatric kidney and urinary tract diseases; 3) an Internal Oversight Committee comprised of three Department
Chairs and three Senior Associate Deans, including the Dean for Faculty Development and Diversity; 4) a
talented, diverse External Advisory Council, including patient representatives; 5) more than three dozen
Training Faculty members from within and outside the host Divisions and Departments, with a broad array of
research interests in basic, translational and clinical investigation; 6) a steady pipeline of enthusiastic,
research-oriented candidates for training in all Program disciplines, despite sharp national declines in interest
in nephrology and pediatric nephrology (and in particular, in research careers within these disciplines); 7) an
outstanding track record of training over the past 10 years, including eight recipients of Career Development
Awards, four of whom have transitioned or are in the process of transitioning to independence, dozens of
recipients (in aggregate) of individual fellowship training awards from NIDDK (F32), American Society of
Nephrology (Ben Lipps Fellowship), American Kidney Fund (Clinical Scientist in Nephrology), American Heart
Association (national and Western States) and the Child Health Research Institute at Stanford, and 582
publications or abstract presentations, 329 (57%) with trainees as lead author; 8) well-established and time-
tested methods of tracking progress of individual trainees and the Program at-large; 9) a truly exceptional level
of focus and dedication to recruitment, retention, and career advancement of women and persons of
underrepresented minority backgrounds; and 10) a measured approach to research training, adherence to all
ACGME recommended practices within residency and fellowship, and a new focus on Wellness. We believe
that our Research Training Program is exceptional. We are mindful of fiscal restraints at NIDDK and NIH more
broadly. However, we recognize the urgency of workforce deficits in adult and pediatric nephrology and
urology (particularly in academic settings) and the burden of kidney and urologic diseases to the public health.
We respectfully request expansion of the Program from four to six slots, which would allow for three fellows in
adult or pediatric nephrology or urology to undertake two years of dedicated training supported by the T32.

Public health relevance
PROJECT NARRATIVE This renewal T32 application seeks to extend funding to a thriving research training program in the NIDDK mission areas of adult and pediatric nephrology and adult and pediatric (benign) urology. Over the past 10 years, we have successfully trained fellows for careers in academics; eight of our recent trainees (including five women) have secured Career Development Awards; half have reached a stage in her or his career where she or he has either received or submitted independent investigator (R01) awards. We have sustained a strong pipeline of candidates and hope to expand our Program from four to six slots in order to help meet scientific workforce needs in adult and pediatric nephrology and urology in the coming decade.